Tissue Engineering Resource Center: TTD

SUMMARY
For TERC renewal, the Technology Training and Dissemination Core has been designed to provide three
related components: training, dissemination, and outreach. Training will provide investigators with the
knowledge and skills necessary for effectively using TERC developed technologies, and to create a new
cadre of biomedical researchers prepared to move the field forward. To this end, we will offer formal
graduate-level courses (e.g., hands-on laboratory classes, stem cell bioengineering classes) for developing
general tissue engineering skills. In parallel, we will offer specialized seminars, lectures, symposia and
workshops tailored to the needs and interests of the trainees (e.g., specialized training in translational
research, clinical research, entrepreneurship and commercialization). In addition, we will offer research
programs for undergraduate, graduate and medical students, and residencies for guest investigators. A
portfolio of training modalities will be posted on TERC website, with regular updates, and made available
free of charge. The second component, Dissemination, will also include a range of modalities that will be
managed through the TERC website. Our weekly lecture series Tissue Talks will be offered to worldwide
audiences. Workshops and symposia organized by faculty and trainees will be offered to all registered
participants to provide forums for discussing developments in the field. Science Simplified, a web-based
initiative started and managed by TERC trainees, will feature recent advances in tissue engineering, in the
form of clear and simple articles suitable for young audiences and non-specialists. The Career
Conversations Podcast, also run by our trainees, will provide invaluable insights into the multiple career
paths. The third component, Outreach, will provide an engaging learning program to underrepresented and
underserved communities, including summer programs for middle school students, Girls Science Day and
summer research for undergraduate students from black colleges. All training, dissemination and outreach
activities will specifically acknowledge NIBIB grant support.